Development of a Cross-Protective New World Encephalitic Alphavirus Subunit Vaccine

7. Project Summary/Abstract
The encephalitic New World alphaviruses (NWAVs), consisting of Eastern, Venezuelan and Western Equine
Encephalitis Viruses (EEEV, VEEV and WEEV, respectively), are transmitted by mosquitoes through rodent
or bird hosts and have caused significant periodic epizootic outbreaks in equines and humans in the Americas.
NWAVs can cause severe neurological disease, with fatal encephalitis in up to 70% of cases, and significant
long-term sequelae in survivors. With recent climate changes, geological redistribution of mosquitoes carrying
NWAVs further enhances the potential for future outbreaks. Moreover, concern over their potential use as
bioweapons is well-founded due to their ease of production, high infectivity, ability for aerosolization, and
capacity to induce disease, resulting in select agent classification for E/VEEV. Despite awareness of these
viruses for nearly 100 years, licensed human vaccines against E/V/WEEV remain unavailable for general use.
The development of next-generation vaccines that can safely and effectively protect humans against these
pathogenic alphavirus infections are urgently needed. This project seeks to develop a cross-protective
recombinant subunit E/V/WEEV vaccine based on the linked ectodomain portions of Envelope 2 (E2) and E1
proteins of each NWAV adjuvanted with SLA-LSQ, a novel TLR4 agonist combined with the saponin QS-21
in a liposomal formulation. The proposed approach provides a means to deliver a safe and stable vaccine to
protect against infection by all three NWAVs using a scalable manufacturing platform that, in combination with
a proven Th1/Th2 balanced adjuvant, elicits a robust, efficacious and durable immune response through both
neutralizing and non-neutralizing means. The proposed NWAV vaccine is based on our highly immunogenic
and fully protective pre-clinical E2/E1 candidate vaccine for the closely related Chikungunya virus (CHIKV).
New preliminary data demonstrates that mice immunized with the NWAV E2/E1 subunits generate high NAb
titers to non-select agent strains of E/V/WEEV. The Specific Aims of this project are: 1) evaluate the
immunogenicity and optimize formulations of individual and combined recombinant E/V/WEEV subunit
proteins with SLA-LSQ adjuvant; 2) demonstrate the ability of the candidate vaccine to induce a durable
immune response in mice; and 3) demonstrate the cross-protective efficacy of the candidate vaccine in mice
upon NWAV challenge. Hawaii Biotech and the Baylor College of Medicine will collaborate to develop,
evaluate and advance this novel trivalent NWAV vaccine candidate. The development of a cross-protective
recombinant subunit vaccine to protect against all three pathogenic NWAVs would provide a valuable medical
countermeasure to safeguard against the considerable threat posed by these encephalitic alphaviruses.

Public health relevance
8. Project Narrative The proposed research is focused on the development of a cross-protective recombinant subunit candidate vaccine against Eastern, Venezuelan and Western Equine Encephalitis Viruses (EEEV, VEEV and WEEV, respectively) that are highly pathogenic in humans. The proposed vaccine combines recombinant glycoproteins from all three New World Alphaviruses into a single formulation. The use of a single vaccine candidate to protect against multiple related encephalitic Alphaviruses provides a valuable medical countermeasure for pandemic threats and a safeguard against biothreats. Validating the success of this vaccine candidate would have a significant impact on human health.